Investigating Trypanosomatid life-cycle transitions using live-cell imaging

PROJECT SUMMARY
Trypanosomatids are important human pathogens that cause severe diseases around the world. These parasites
feature free living life-cycle stages that have previously been intractable to rigorous study using long term live-
cell imaging because most confinement strategies disrupt cellular processes or cause death. This has left
significant gaps in knowledge about the rates of cellular events such as cell division and if states seen in fixed-
cell imaging represent bona fide intermediates of cellular processes or are strictly endpoints or fixation artefacts.
We recently devised a strategy using agarose microwells cast from PDMS stamps to confine trypanosomatids
in nanoliter volumes of media without impacting their motility or viability. These volumes are sufficiently small
that 10 to 25 microwells fit within the imaging volume of an inverted microscope, allowing us to observe multiple
cells during one imaging run, which can last as long as 3 days using white light and fluorescence. The method
is also compatible with small molecule and RNAi treatments, which allows novel investigation of loss-of-function
experiments. We have used the agarose microwell method to study the cell division mechanism of Trypanosoma
brucei and Trypanosoma cruzi, showing that the daughter cells produced by the parasites subsequently divide
at different rates, which suggests that the inherent asymmetry in the daughter cells takes different amounts of
time to resolve before they can divide again. We also showed that an intermediate that appears in fixed samples
during RNAi that was proposed to function as an alternate cell division mechanism could be observed during live
cell imaging, but that it did not lead to productive cell divisions, which emphasizes the value of our approach.
We have updated our microscope to increase the number of microwells that we can observe simultaneously
and decrease the amount of light we need to image cells. This update has now made it possible to observe rare
or asynchronous events, such as life-cycle transitions, that also appear to be more sensitive to light exposure.
We will use our updated imaging approach to study a variety of life-cycle transitions in both T. brucei and T. cruzi.
In Aim 1a, we will be studying the mechanism of metacyclogenesis T. brucei, which produces parasites that are
ready for transmission into the mammalian host, to determine how the parasite replaces cell surface proteins
and how it reorganizes the cell body. In Aim 1b, we will study the T. brucei slender to stumpy transition, which
preadapts bloodstream form parasites for transmission back into the insect host, using recent scRNA-seq data
to identify intermediate states in the process. In Aim 1c, we will determine if the switch from the insect-resident
epimastigote form to the metacyclic trypomastigote form in T. cruzi, which requires a significant repositioning of
the flagellum and all its associated structures, requires a cell division to occur and how attachment to a surface
affects the transition. Our work will provide unprecedented details about the mechanisms of trypanosomatid life-
cycle transitions, which are poorly understood and could yield new avenues for blocking parasite transmission.

Public health relevance
PROJECT NARRATIVE Trypanosomatids are highly motile single-celled parasites that cause a range of deadly diseases around the world. Imaging live trypanosomatids has proven difficult, which has greatly limited our understanding of key events during the parasite life cycle, which are essential for elucidating how these parasites infect their hosts. We have developed a strategy employing agarose microwells that allows live trypanosomatids to be imaged for days, permitting us to directly observe how these parasites undergo life cycle transitions for the first time, which will answer many open questions about their biology.